"12th Biennial Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM)"

ABSTRACT
The 12th Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) will be held February 5-7, 2023 at
Wintergreen Resort and Conference Center near Charlottesville, Virginia. The purpose of the MAMPM is to
foster communication and collaboration among microbial pathogenesis researchers in the Mid-Atlantic region
(North Carolina, Virginia, Maryland, The District of Columbia, West Virginia, and Delaware). Research
presented at MAMPM is highly relevant to FDA's mission, particularly in the development of novel vaccines,
diagnostic and treatment platforms for the human diseases, and protection the public against the threats of
emerging infectious diseases. Numerous FDA-funded investigators studying the virulence mechanisms of
pathogens of importance to human health are in this geographic region.
One of MAMPM’s key goals is to provide students, postdoctoral fellows, and junior faculty with the
opportunity to present their work to a knowledgeable audience, focused on this discipline, in a collegial yet
scientifically rigorous environment. Conference evaluations consistently show MAMPM is a formative
experience for young scientists’ professional development and remains one of the most appealing, and
positively evaluated, aspects of this conference. MAMPM 2023 is arranged by the Organizing Committee
consisting of the current, future, and past two conference chairs. The vast majority of talks are selected from
abstracts and presented by graduate students, postdoctoral fellows, and junior faculty. Four internationally
renowned keynote speakers introduce each session: Drs. Sunny Shin (U Penn), Carlos Orihuela (U Alabama
Birmingham), Craig Altier (Cornell Univ.), and Patricia Champion (Univ Notre Dame). Two highly interactive
poster sessions will be held to allow the opportunity for all participants to present and discuss their work.
MAMPM 2023 will be publicized through advertisements in professional publications, social media posts, and
direct mailings to relevant departments at academic institutions, government and private laboratories within the
region and to members of the local American Society for Microbiology branches that serve this region. A
dedicated website (http://mampm.org/) publicizes the meeting and provides the necessary information and
forms required for registration.
MAMPM remains committed to ensuring a balanced representation of women, underrepresented
minorities, and persons of disability in the leadership, conference participants, and speakers, including keynote
speakers. The conference will also feature a moderated, diversity-focused event that is open to all conference
attendees; the discussion will be driven by topics and questions related to diversity and inclusivity in the
microbial pathogenesis field, solicited from attendees prior to the meeting. In addition, the meeting will include
“Dine with a Keynote” opportunities for trainees to discuss professional development issues.

Public health relevance
PROJECT NARRATIVE The purpose of the 12th Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) in February 5-7, 2023 is to foster communication and collaboration between scientists engaged in research focused on disease-causing microbes in this geographic region. The goal of the organizers is to assemble a high-quality scientific program to attract outstanding principal investigators along with their undergraduates, laboratory technicians, graduate students, post-doctoral fellows, and junior faculty. This meeting will provide an opportunity for junior scientists to present their work to a knowledgeable audience in a supportive and collegial environment.